Non-Invasive Probing Cellular Oxidative Stress and Antioxidants Therapeutic Effectiveness

PROJECT SUMMARY.
Particulate matter (PMs) that induces oxidative stress have prominent impacts and adverse health effects
including increased cardiovascular and pulmonary diseases. The World Health Organization recognizes diesel
engine particles (DEPs) as mutagenic and carcinogenic to humans and the International Agency for Research
on Cancer (IARC) classified diesel engine exhaust as a human group I carcinogen. It has been established that
generation of reactive oxygen species (ROS) and oxidative stress is an important toxicological mechanism of
particulate air pollution-induced lung cancer and disorders. However, the pathophysiological mechanism of air
pollutant mediated pulmonary toxicity still remains unclear. This is primarily due to the lack of efficient test
systems, mimicking human air pollutant inhalation exposure scenarios. Furthermore, it is unclear, but important,
to understand whether epithelial cells from different respiratory tract regions respond to PMs similarly or
differently and how to develop measurement technology to assess responses in both in vitro and in vivo. Dietary
interventions with antioxidants (e.g., resveratrol), polyunsaturated fatty acids (PUFA, such as docosahexaenoic
acid or DHA) are an attractive therapeutic approach to ameliorate air pollution-induced respiratory toxicity.
Current methods to detect cellular ROS are fluorescence-based, suffering several drawbacks: each fluorescent
dye is limited to a couple of ROS species, not detecting the overall ROS production; single-cell resolution is not
achievable; lack of both molecule-level details and temporal specificity; and the photobleaching problem. The
primary goal of this proposal is to test the application of a non-invasive, non-destructive, label-free Raman
spectroscopy technique in combination with machine learning analysis to assess cellular oxidative stress and
cytoprotection by antioxidants. Our central hypothesis is that subcellular and biochemical composition alterations
induced by oxidative stress and intracellular ROS production can be quantitatively detected in the cell by Raman
spectroscopy using the combinational analysis of respective spectral markers of the fingerprint and the silent
regions. To accomplish this goal, we propose the following specific aims: 1) In vitro toxicity assessment of
epithelial cells exposed to DEP and the effects of antioxidants; 2) Identification of oxidative stress-associated
spectral markers in the fingerprint region and development of intracellular ROS sensing nanoprobes in the silent
region; and 3) Pre-validation of Raman-derived spectral markers and ROS quantitation on the lung tissues
isolated from DEP exposed mice. We expect that successful completion of these aims will yield a wealth of new
knowledge regarding the mechanistic link(s) between cellular oxidative stress biomarkers and non-physiological
spectral markers. Further, we expect that these experiments will establish a new technical platform for screening
antioxidant activities that can benefit the discovery of new therapeutic agents to battle PM-induced lung disease
and other oxidative stress induced inflammatory diseases.

Public health relevance
PROJECT NARRATIVE The proposed work is relevant to public health and focuses on developing a non-invasive, label-free spectroscopic technique in combination with machine learning algorithms to quantitatively detect and predict air pollution particulate matter (PMs) induced oxidative stress in different respiratory tract cells and also assess the effectiveness of antioxidant treatment. Successful completion of this study will lead to new technologies that will enable highly sensitive, high-throughout, and direct screening of many previously untested antioxidant therapeutic compounds for air pollution derived lung diseases.